The consequences of the unusual mutation responsible for the Repeat Expansion Diseases

Background: The Repeat Expansion Diseases (REDs) are a group of 40+ human genetic disorders that are caused by expansions of a disease-specific tandem repeat or microsatellite. These diseases include 11 that result from the presence of a large CGG-repeat tract present with the transcriptional unit of the affected gene. In those diseases involving very large repeats, referred to as full mutation (FM) alleles, repeat-mediated gene silencing occurs. This results in a deficiency of the protein product of the affected gene that is the proximal cause of disease pathology. In the case of Fragile X syndrome (FXS), the most common heritable cause of intellectual disability and autism, the silenced gene is the Fragile X Messenger Ribonucleoprotein 1 (FMR1) gene. As a result, the amount of the protein product of FMR1, FMRP, is severely reduced. FMRP is involved in, amongst other things, the regulation of translation in the brain, as well as insulin signaling and glucose metabolism. In contrast, mid-size repeat tracts, so-called premutation (PM) alleles, are often hyper-expressed, with pathology arising via some deleterious consequence of the expression of transcripts with larger than normal numbers of CGG-repeats, the nature of which is the subject of much debate. This results in a form of neurodegeneration known as Fragile X associated tremor/ataxia syndrome (FXTAS) and a form of ovarian dysfunction known as Fragile X associated primary ovarian insufficiency (FXPOI). Other CGG-REDs show a similar pattern of hyper-expression of mid-size alleles and silencing of larger ones. In addition, large, silenced alleles in many of these diseases are associated with a folate-sensitive fragile site that colocalizes with the affected gene (Lokanga, Kumari and Usdin, 2021).

Our previous work has helped define the heterochromatin landscape associated with Fragile X alleles, identified the likely timing of the silencing window and implicated the FMR1 transcript in the silencing process. We were also amongst the first to show that repeat-mediated gene repression also occurs in Friedreich ataxia, a disorder resulting from a GAA-repeat expansion in the first intron of the frataxin (FXN) gene and more recently we showed that epigenetic silencing is also seen in a glutaminase deficiency disorder resulting from a CAG (GCA)-expansion in the 5 UTR of the Glutaminase 1 (GLS1) gene. In this review period we have continued our studies on the molecular events associated with gene silencing and reactivation in FXS and on the identification of new small molecules that can block gene silencing. In the process we have uncovered new evidence for the effect of long CGG-repeats on chromosomal integrity and the processes involved in preventing deleterious chromosomal rearrangements. We have also initiated studies in collaboration with the Tassone lab to examine the relationship between repeat length, somatic expansion and disease pathology in carriers of FMR1 PM alleles (Hwang, 2022). We are also continuing our efforts to identify new Repeat Expansion Diseases and to help with the diagnosis of unusual cases of previously identified diseases (e.g., Fazal et. al., 2022).